Regulation of the double-stranded RNA (dsRNA) response in gastric metaplasia and dysplasia

PROJECT SUMMARY/ABSTRACT
Gastric metaplasia represents a critical pre-neoplastic event in the progression to gastric cancer, one of
the leading causes of cancer-related deaths worldwide. The extent of gastric metaplasia is a significant
indicator of gastric cancer incidence. While we recognize that metaplastic epithelium is characterized by the
loss of acid-secreting parietal cells and a reprogramming of zymogenic chief cells to a proliferative phenotype,
we still lack a mechanistic understanding of how gastric epithelium regulates cellular stress during metaplasia
and what signaling pathways determine the progression to cancer.
My preliminary findings identified the response to double-stranded RNA (dsRNA) as the most highly
upregulated pathway across two distinct metaplasia-inducing models in mice, suggesting that dsRNA signaling
represents a conserved, metaplastic pathway. In addition, my independent analysis found that the dsRNA
response was one of the most significantly downregulated pathways in human gastric cancer. Though the
dsRNA response has often been studied in the context of viral infection, these findings would suggest that the
epithelial regulation of the dsRNA response is crucial to gastric metaplasia and tumorigenesis.
This application proposes to define how the regulation of the dsRNA response affects the
establishment of gastric metaplasia and the progression to dysplasia. As part of my first Aim, I will determine
the necessity and sufficiency of dsRNA signaling in gastric metaplasia, using established gastric organoid and
in vivo models. More specifically, I will characterize how the dysregulation of the dsRNA response in chief
cells, an epithelial lineage critical to the metaplastic response, affects the development of gastric metaplasia in
vivo. This will rely on a newly developed murine model where a key regulator of dsRNA signaling, ADAR1, can
be conditionally and specifically deleted from chief cells. Along those lines, a similar mouse model that I
developed found that specific deletion of ADAR1 from parietal cells resulted in gastric dysplasia, implying
lineage-specific effects of dsRNA signaling in gastric tumorigenesis. My second Aim will examine the role of
dsRNA signaling in parietal cell fate by transcriptionally characterizing Adar1-deficient parietal cells at distinct
stages of parietal cell development. In addition, this Aim will define the role of Tnfrsf11b, one of the most highly
upregulated genes in my murine model of gastric dysplasia and a gene found to be upregulated in human
gastric cancer, in promoting the dysplastic milieu. The experiments proposed in this application are informed
by some of the objectives from my K08 award, but they will investigate new experimental approaches that will
complement and expand on these hypotheses. More importantly, these findings will offer new mechanistic
insight into the contribution of dsRNA signaling to gastric tumorigenesis and potentially lead to new diagnostic
and therapeutic alternatives.

Public health relevance
PROJECT NARRATIVE A crucial step in the progression to gastric cancer, the third leading cause of cancer-related deaths worldwide, is the development of gastric metaplasia. We still lack a mechanistic understanding of the host pathways that characterize metaplastic epithelium and how the dysregulation of these pathways can lead to cancer. The proposed research will specifically address the role of double-stranded RNA (dsRNA) signaling, a previously unexplored pathway, in the development of metaplasia and the progression to dysplasia in gastric epithelium.